Role of HIF-1 in Intervertebral Disc Function

DESCRIPTION (provided by applicant): Degenerative disc disease is closely linked to the generation of back pain and other spinal pathologies, which for millions of Americans represents a difficult part of the aging process. In the intervertebral disc, the cells of the nucleus pulposus (NP) function in a unique environmental niche, characterized by a very limited vascular supply that imposes metabolic constraints and a hypoxic state on cells. We have shown that in the NP, HIF and PHD form a unique regulatory circuit: PHD2 controls degradation of HIF-1α even under hypoxia, while PHD3 promotes its transcriptional activity. For the first time, we have demonstrated that HIF-2α is insensitive to PHD mediated degradation. Conversely, HIF-1α homologues differentially control PHD expression in the NP in a cell type specific manner. Directly relevant to disc disease, our pilot data suggests that the HIF-PHD circuit can be decoupled by inflammatory cytokines TNF-α and IL-1ß. Based on this information, we propose to investigate how HIF controls PHD function in the hypoxic NP niche, given that PHDs require molecular O2 as a substrate for their catalytic function. We will determine mechanisms underlying differential sensitivity of HIF-1α homologues to PHD mediated degradation as well as elucidating the identity and function of co-factors that are recruited to HIF-1α in a PHD dependent fashion. To relate this information to the in vivo state, we will conditionally delete HIF-1α in the notochord as well as post natal NP and analyze the mutant mice for changes in cell proliferation, survival and differentiation. Next, we will investigate the mechanisms by which TNF-α and IL-1ß decouple the HIF-PHD circuit and test the hypothesis that PHD3 mediates the effects of cytokines on NP cells. Lastly, we will test the hypothesis that PHD3 inactivation slows the progression of degenerative changes in the disc in vivo under inflammatory condition. Conversely, we will ascertain if perturbation of the HIF-PHD circuit in PHD3 null mice influences age dependent changes in the disc. Taken together, the proposed studies will thus test a novel hypothesis in disc research, namely, the HIF-PHD regulatory network is critical in maintenance of NP cell survival and function and decoupling of this circuit by inflammatory cytokines may exacerbate degenerative disc disease. Outcomes from these studies will lead to the development of new pharmacological interventions aimed at maintaining the structural integrity of the disc and mitigating the inflammatory response.

Public health relevance
PUBLIC HEALTH RELEVANCE: Lower back pain experienced by millions of Americans is closely linked to degenerative disc disease, a condition that afflicts the spine. The goal of the proposal is to understand the mechanism by which cells in the disc survive in a hypoxic environment and respond to inflammatory conditions prevalent during disc disease.